Astrocyte Reaction in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
The proposed research focuses on investigating the role of astrocyte reaction in Alzheimer's disease (AD).
Much of AD research has focused on the two pathological hallmarks of the disease -amyloid plaques and
neurofibrillary tangles- and their effects on neurons and synapses. Reactive astrocytes are universally present
in neurodegenerative diseases, and in AD they react to plaques and tangles, but whether they contribute to
neurodegeneration or are neuroprotective remains uncertain.
The applicant's research strategy aims at a deep phenotyping of astrocytes in AD mouse models and the
human AD brain. The hypothesis to be tested is that astrocyte phenotype changes along the course of AD, from
neuroprotective to neurotoxic, and perhaps senescent astrocytes in the end-stage. Importantly, this project
builds upon prior observations made by the applicant using stereology-based quantitative methods in human
brain specimens, while moving towards experimental grounds and extending his skillset including astrocyte
purification methods, RNA-seq, bioinformatics, astrocyte-specific manipulations in AD mouse models with
viral-mediated gene delivery, novel histological methods (i.e. cyclic immunofluorescence, array tomography),
and biochemical methods (i.e. sequential protein extraction, synaptoneurosome preparations).
The candidate's research environment is ideal for the project. The Massachusetts General Hospital and
the Harvard Medical School are a nurturing atmosphere for trainees, and have multiple core facilities. The
MassGeneral Institute for Neurodegenerative Diseases and the Massachusetts Alzheimer's Disease Research
Center are first rank infrastructures devoted to research on AD and other neurodegenerative diseases.
The candidate's mentoring team is composed of a world-class AD researcher (Dr. Bradley Hyman), a
renowned neuropathologist (Dr. Matthew Frosch), and an early PhD investigator with expertise in AD mouse
models and molecular biology tools including viral-mediated gene transfer (Dr. Eloise Hudry). The advisory
team will contribute with expertise in viral-mediated gene transfer (Dr. Xandra Breakefield), astrocyte biology
and pathology (Dr. James Goldman), and RNA-seq and astrocyte synaptic functions (Dr. Beth Stevens).
The candidate's training plan includes both career development lectures on relevant topics (i.e. grant
writing, scientific communication, and training in responsible conduct of research), as well as a series of
intensive Harvard Catalyst courses that are pertinent to the proposed research (i.e. Certificate in Applied
Biostatistics, Introduction to Omics Research, Introduction to RNA-seq).
The combination of a nurturing research environment, experienced mentoring and advisory teams, and a
comprehensive training plan, with allow the applicant to fulfill his short and long-range career goals, which
are deciphering the role of astrocyte reaction in AD and transitioning towards an independent clinician
scientist position, respectively.

Public health relevance
PROJECT NARRATIVE The functional and molecular diversity and complexity of astrocytes in the healthy brain has just started to unfold. As in other neurodegenerative diseases, in Alzheimer's disease neuronal loss is invariably accompanied by an astrocyte reaction —traditionally depicted by an increased immunoreactivity for the glial fibrillary acidic protein (GFAP)—, but whether these reactive astrocytes are neuroprotective, neurotoxic, or mere bystanders, and whether there are distinct astrocyte phenotypes or sub-populations beyond “GFAP-immunoreactive” astrocytes remain unanswered questions. With this research proposal, I am aiming at deciphering both the phenotypic diversity of astrocyte reaction in Alzheimer's disease and the contribution of GFAP up-regulation to astrocyte phenotypes, by using a combination of transcriptomic, histological, biochemical, and viral-mediated gene delivery approaches, and both mouse models and human postmortem brain specimens.